Endovascular Health and Platelet Activity in Psoriasis

PROJECT SUMMARY/ABSTRACT
Background: Psoriasis is a common chronic inflammatory skin disease associated with an ~50% increased risk
of cardiovascular disease (CVD) compared to matched controls. The influence of psoriasis-related systemic
inflammation on vascular health and subsequent cardiovascular (CV) risk is not fully known. Vascular endothelial
dysfunction, activated platelets, and the interaction between the two are instrumental to the pathogenesis of
atherosclerosis. As a way to understand mechanisms of increased CV risk in psoriasis, this study will test the
overarching hypothesis that the vascular endothelium in psoriasis is inflamed, dysfunctional, and contributes to
CVD development as assessed by endovascular and platelet phenotyping, and that platelets from patients with
psoriasis act as effector cells promoting impaired vascular health. To develop therapeutic targets to reduce CV
risk, mechanism(s) that lead to the development of clinical CVD must be clarified.
Preliminary Data: Our group has shown using direct brachial vein endothelial cell analysis, that patients with
psoriasis exhibit impaired vascular endothelial health. Furthermore, unbiased analysis highlights
inflammasome (IL-1β) signaling with downstream IL-6 protein production as the highest differentially expressed
systemic pathway in psoriasis and correlated with impaired endothelial vascular health. Our preliminary data
also reveal that patients with psoriasis overexpress P-selectin (a marker of platelet activation), directly activate
cultured human aortic endothelial cells in vitro, and that markers of platelet activation correlate with serum IL-6
levels. This suggests that platelets contribute to the impaired vascular health we observe in psoriasis. These
findings have clinical implications because randomized clinical trials targeting the inflammasome pathway (with
a corresponding circulating IL-6 reduction) in patients with established CVD reduced cardiac events.
Methods: We will recruit 100 psoriasis and 50 healthy age-, sex-, race/ethnicity matched controls across the
spectrum of psoriatic disease and various treatment modalities to explore: (1) Vascular health in vivo by flow-
mediated brachial artery reactivity testing and pulse wave velocity studies, and directly ex vivo via analysis of
endothelial cells obtained from brachial veins; (2) Platelet biology through investigations into platelet reactivity,
platelet aggregation, and the platelets ability to activate endothelial cells in vitro.
Objectives and Career Development: No study has shown that targeting psoriatic disease activity reduces
the development of CVD. This proposal uses a highly collaborative environment between experts in CV and
platelet biology, immunology, dermatology, and rheumatology. It will lay the groundwork to propose future
larger-scale studies designed to reduce CV risk in patients with psoriasis. Furthermore, it will allow the PI to
become an expert in pro-inflammatory conditions, refine innovative methodologies and laboratory techniques
to study mechanisms of subclinical CVD, and provide a framework to become an independent clinical-
translational investigator.

Public health relevance
PROJECT NARRATIVE Psoriasis increases the risk of cardiovascular disease 50% above matched controls. This study will investigate mechanisms in the development of cardiovascular disease by characterizing vascular endothelial disturbances and platelet reactivity in patients with psoriasis. We aim to identify potential therapeutic targets with the eventual goal of developing therapeutic interventions to reduce cardiovascular disease in this at-risk population.